Impacting the oral HPV continuum: prevention, screening, and early detection

Human papillomavirus (HPV) causes the majority of oropharyngeal cancers in the United
States, but we do not yet have any effective screening methods to detect these cancers. This
knowledge gap is in part due to difficulties identifying oropharyngeal precursor lesions.
However, several promising salivary and blood biomarkers have recently emerged that may be
good markers of persistent oral HPV16 infection, the presumed pre-cursor to HPV-related
oropharyngeal cancer. Given the increasing incidence of HPV-related oropharyngeal cancer, I
propose to study the oral HPV continuum to answer the following 4 questions: 1) who is at high-
risk for HPV-OPC and would benefit from screening, 2) What are the biologic and behavioral
factors promoting oral HPV persistence and how can we reduce their effects, 3) how to optimally
screen for persistent oral HPV16 infection and HPV-OPC, and 4) How to follow and treat people
who screen positive for these biomarkers to prevent the development of HPV-related
oropharyngeal cancer.

Public health relevance
Narrative / Relevance This study explores who is at high risk for persistent oral HPV16 infection and progression, how to best screen these individuals, and how to follow and treat screen-positive individuals to prevent HPV-OPC development. Understanding the biologic and behavioral risk factors for persistent oral HPV infection, and how to effectively screen those at highest risk of progression, will inform prevention and early detection of these cancers.